Efficacy of Hypoxic Red Blood Cells Processed with the Hemanext ONE® System in Patients with Sickle Cell Anemia

Project Summary/Abstract
Sickle cell anemia (SCA) is one of a group of inherited red blood cell (RBC) disorders known as
sickle cell disease (SCD). The disease is caused by a single point mutation that results in abnormal
hemoglobin (Hb), also known as sickle hemoglobin (HbS). Two types of hemoglobin abnormalities cause
the most severe SCA - HbSS and hemoglobin beta zero thalassemia (Hb S/β0). A type of blood transfusion
therapy, known as red cell exchange (RCE) therapy, is used to improve anemia by decreasing the proportion
of HbS relative to normal hemoglobin (HbA), thereby increasing oxygen (O2)-carrying capacity to alleviate
symptoms and prevent complications. However, conventional transfusion methods come with inherent risks
such as iron overload and alloimmunization, highlighting the need for alternative strategies. Despite several
new therapies that have been developed over the past few years, including pharmacologic and gene therapy,
they are not available or tolerable to all patients. These anemic patients continue to require RBC transfusions.
Chronically transfused SCA patients are the most highly vulnerable of the “vulnerable populations” because
they are entirely dependent on regular, high-quality blood products to remain healthy, and for those patients,
blood transfusion therapy is the only viable option for survival.
Hypoxic red blood cell (HRBC) transfusions have emerged as a promising approach to potentially
improve treatment outcomes in SCA patients. Hemanext’s research has confirmed that storage of RBCs at low
Hb O2 saturation (SO2) levels maintains more viable cells during storage and preserves the cells in a more
physiologically optimal state by reducing oxidative damage and enhancing cell metabolism.
This trial aims to rigorously assess, for the first time, the efficacy of HRBC transfusions compared to
conventional RBC (CRBC) transfusions. By employing a multi-center, randomized, cross-over design, the trial
will enroll 48 SCA patients across five United States (US) academic medical centers. The primary objective
will evaluate the efficacy of HRBCs by measuring the rate of decline in %HbA and assessing its impact on
reducing transfusion burden and, hence, transfusion-related outcomes including a comprehensive array of
clinical and laboratory parameters and quality of life assessments. Patients will be randomized to receive either
hypoxic or conventional RBC transfusions for six months. This will be followed by a "washout" phase and
subsequent cross-over to the alternate treatment arm for another six months. Statistical analyses will employ
robust methods to compare treatment effects.
Demonstrated efficacy of HRBC transfusions could lead to a paradigm shift in transfusion therapy,
potentially reducing complications and healthcare costs while improving patient outcomes. The long-term
implications of this research extend beyond the realm of SCA to benefit patients with various hematological
and acquired bleeding disorders and advance healthcare practices globally.

Public health relevance
Project Narrative Despite several new therapies that have been developed over the past few years including pharmacologic and gene therapy, they are not available or tolerable to all sickle cell patients. Chronically transfused SCA patients continue to be the most highly vulnerable of the “vulnerable populations” because they are entirely dependent on regular, high-quality blood products to remain healthy, and for those patients, blood transfusion therapy is the only viable option for survival. This project aims to transform transfusion therapy for SCA patients by evaluating the efficacy of Hemanext ONE® hypoxically stored red blood cells (HRBCs) compared to conventional RBCs (CRBCs) in a chronically transfused population of children and adults by performing a multi-center, randomized, clinical study involving 48 SCA patients across five academic medical centers in the United States.